Understanding Health Inequities at the Intersection of the HIV and substance use epidemics across racial/ethnic and other underserved populations

People with HIV (PWH) in underserved racial/ethnic and marginalized populations (UREMP) carry a
disproportionate burden of health disparities related to substance use and HIV. The goal of this study is to
elucidate and address disparities experienced by UREMP in substance use patterns, substance use treatment
outcomes and HIV-related outcomes including the contribution of social, cultural, structural, and other factors.
We focus on underserved racial/ethnic populations as well as other marginalized groups such as those who
are transgender, have unstable housing, or were recently incarcerated. We will 1. Determine
methamphetamine, cocaine and opioid-related behaviors, risk factors, and treatment outcomes to better
understand health disparities among UREMP and better tailor future intervention/treatment and prevention
approaches. We will examine differences in drug-related behaviors including types, frequency, severity of use,
mode of administration, polydrug use, overdoses, Naloxone access, and substance use treatment access and
outcomes. We will determine the role of demographic, behavioral, psychosocial and clinical factors, and
incorporate additional structural/social measures such as of racial/ethnic identity, stigma/discrimination, and
other domains based on recommendations from community partners, end-users, and critical thought partners
to determine risk factors for differences in drug use patterns and substance use treatment outcomes. 2.
Determine the role of methamphetamine, cocaine and opioid use in HIV-related outcome disparities among
UREMP. We will examine longitudinal relationships between drug use, social, cultural, and structural factors,
and HIV care cascade steps such as engagement in care, viral suppression and health-related quality of life.
We will determine the impact of drug use and social, structural, and other factors on age-related comorbidities,
such as diabetes, frailty, myocardial infarction and chronic kidney disease among UREMP. We leverage the
large well-characterized racially/ethnically, gender, and sexual orientation-diverse cohort of PWH with
comprehensive clinical data in the Centers for AIDS Research Network of Integrated Clinical Systems (CNICS)
cohort. The CNICS patient reported outcomes assessment captures detailed drug use patterns, psychosocial,
behavioral and other factors such as social support and racial stigma/discrimination and facilitates capturing
multiple dimensions of identity. CNICS geocoding and carefully adjudicated outcomes facilitates including
structural factors and evaluation of HIV-related comorbidities. CNICS data and our team bring a breadth and
depth of resources, responding to RFA-DA-23-061 by generating new knowledge about substance use-related
disparities among PWH from UREMP and the impact of social, structural, and cultural factors. This study will
inform future research and assist end-users within our community partnerships in tailoring future substance
use treatment programs to the unique needs associated with people’s multidimensional identities in order to
reduce disparities among populations affected by inequities at the intersection of HIV care and substance use.

Public health relevance
PROJECT NARRATIVE. The goal of this proposal is to develop a better understanding of social, cultural, structural and other factors that drive health disparities for underserved racial/ethnic and marginalized populations at the intersection of HIV and substance use, particularly methamphetamine, cocaine/crack, and illicit opioid use. We work with community partners and other end-users to examine disparities in substance use patterns of use, treatment, overdoses, and HIV care and comorbidities among marginalized populations of people with HIV including not only racial/ethnic populations, but also transgender people, those with unstable housing, those recently incarcerated, and others. This study will inform future research, interventions, and assist end-users within our community partnerships in tailoring future substance use treatment programs to the unique needs of multidimensional identities in order to reduce disparities among populations severely affected by inequities at the intersection of HIV care and substance use treatment.